CLINICAL PHARMACOLOGY OF IVX-E-59 IN HIV USING (2-14C)AZT-P(2'3-3H)DDI

The purpose of this study is to elucidate the metabolic and pharmacokinetic profile of IVX-E-59 in HIV-infected patients. The linearity of single-dose pharmacokinetics and absolute bioavailability of IVX-E-59 after oral administration will be assessed.